Dynamic mechanisms of transcriptional coactivator function in Notch signaling

Project Summary
Transcription factors are proteins that control the expression of target genes. Key questions about transcription
factor function include: how does their DNA binding activate transcription? How do activation domains interact
with specific co-factors? What sequence features are required for activity? As a model system to address these
fundamental questions, I will use the transcriptional output of the Notch signaling pathway. The Notch pathway
is essential for development of multiple tissues and its aberrant activity is associated with disease including
cancer. Upon signal activation, Notch assembles a transcription complex (NTC) on DNA, consisting of the DNA
binding protein RBPJ, the Notch intracellular domains (NICD), and a MAML family co-activator. MAML proteins
are thought to act as a platform for assembly of co-factors required to activate transcription, but a thorough
identification of these factors, how they regulate transcription, and how MAMLs interacts with them are unknown.
This study will combine a variety of experimental approaches that allow temporal resolution of transcriptional
induction and transcriptional complex assembly in response to signaling activation. This work will identify co-
activators that interact with the primary MAML protein in humans, MAML1, using APEX2-based proximity
labeling, and will interrogate the dynamics of the transcriptional response using nascent transcriptomics (Aim 1).
In the independent phase of this aim, it will determine how these co-activators work with the NTC to induce gene
expression. This study will directly visualize MAML1 nuclear dynamics in response to Notch activation, and
assess the role of higher order protein assemblies in Notch dependent transcription (Aim 2). It will also identify
the sequence features of MAML1 that confer transcriptional activation activity (Aim 3). Successful completion of
these aims will both elucidate how Notch signaling activates transcription, and more broadly provide key
mechanistic insight into transcriptional activation domain function. This multidisciplinary proposal provides an
excellent training opportunity for the PI, enabling her to expand her repertoire of techniques to study transcription
factors in their cellular context, and strengthen her expertise in gene regulation. The combined mentorship from
Dr. Stephen Blacklow, expert in structural mechanisms of Notch signaling, and Dr. Karen Adelman, leader in
mechanisms of transcriptional regulation, will provide an exceptional environment for the PI to complete this work
and gain the skills necessary to transition to independence. The extensive training plan will equip the PI to
achieve her goal of running an independent laboratory studying mechanisms by which transcription factors
activate specific gene expression patterns. Participation in the MOSAIC UE5 programs will expand the PI’s
network and provide mentoring and leadership skills to empower the PI to promote diversity in academic science.

Public health relevance
Project Narrative Cells must appropriately regulate expression of genes in response to external signals. The Notch signaling pathway is a major developmental signaling pathway whose activity is dysregulated in diseases including cancer. This project will use genomic, proteomic, and imaging approaches to elucidate the mechanisms by which activation of Notch signaling turns on the expression of target genes.